Response to Aerobic Exercise in Patients with Pulmonary Hypertension

The protocol has been approved by the NIH-NHLBI IRB, a contract for the Protocol Manager, Michelle Kennedy, to oversee compliance with the protocol procedures was awarded as was a contract for a scientist from George Mason University, Dr. Randall Keyser. Solicitations have been developed and awards will be extended to collaborators who demonstrate an expertise in Pulmonary Hypertension Rehabilitation. [unreadable] [unreadable] In the Rehabilitation Medicine Department, researchers and investigators meet on a weekly basis (either in person or via conference calls) to continue to refine study implementation procedures (on paper). An in-service was held with scientists and Oxycon, the company that developed the Near Infrared Spectroscopy (NIR), to better acquaint staff to the functions of the equipment. [unreadable] [unreadable] The pilot portion of this study has begun; seven healthy subjects have been tested. The purpose of these studies is to create a smooth operating environment and to assess any potential problems that we might encounter in exercise testing and training of patients and secondary hypertension. These healthy volunteers will help with safety assurance; the data will not be included in the final results. These subjects have been in the age range of those in the clinical trial: 21-74 years of age. The subjects have been healthy and have met all inclusion criteria for the pilot study including physical inactivity, no cardiorespiratory or pulmonary disease, no other disease of the neurological, metabolic, renal, or musculoskeletal system, and no medications that would influence aerobic capacity or treadmill performance. These subjects do not have any of the exclusion criteria specified for the pilot study including, but not limited to, ongoing tobacco use, pregnancy, mitochondrial disease, uncontrolled Diabetes Mellitus with a history of DKA or active substance abuse.